Prediction and Prevention of Hypoglycemia in Veterans with Diabetes

Control of hyperglycemia to prevent or delay the onset of vascular complications is a fundamental goal
of diabetes care. Intensive treatment is limited, however, by risk of hypoglycemia, a common and potentially
hazardous metabolic complication of glucose-lowering treatment. Traditionally, this risk was considered
unavoidable during treatment but new models of care focus on improving the safety of treatment while
optimizing glycemic control. To monitor for safety and foster better care, work is needed to develop
standardized methods and strategies for performance evaluation.
The proposed research employs multiple methodologies to address the issue of hypoglycemia and
improved safety of diabetes treatment. For identification of the condition in the Veteran patient population with
diabetes, we propose to analyze national VA and non-VA structured data and claims, measure patient-reported
experience through patient surveys collected from stratified random samples of patients, and develop accurate
and efficient natural language processing (NLP) tools to search documentation in the medical records for
evidence of hypoglycemia. This will include development of a valid case-finding algorithm. These measures
will be combined and compared to obtain a unique and comprehensive evaluation of the condition in the
patient population and to provide practical information on the accuracy and completeness of various methods.
Patients with identified hypoglycemia will be followed forward to evaluate the risks of subsequent adverse
outcomes associated with the condition, including repeat hypoglycemia, preventable hospitalizations, and
death. We will combine all available and relevant information and model hypoglycemia to identify predictors in
the sample of patients who completed the survey and in the whole VA diabetes population, limiting candidate
predictors to factors available from structured medical data or from NLP extractions. We will identify those
factors obtained from surveys or NLP extraction that add substantially to the predictive models. These models
will inform the process of developing parsimonious predictive algorithms for the whole population and in
relevant subgroups. Risk algorithms will include branching to classify patients by contextual factors that are
useful in guiding clinical management. The best practical algorithms will be implemented in an integrated
system for near real-time hypoglycemia case finding and assignment of diabetes patients by predicted
hypoglycemia risks.
This work will generate methods and tools for monitoring population health and safety among Veterans
with diabetes and for improving care to reduce risks. The near real-time hypoglycemia case-finding and risk
assignment system will be available for use by operations and research as it is implemented. This work could
form the basis for new measures of care quality, providing technologies for risk adjustment, facility and
provider profiling, and practice evaluations. It could be used in generating clinical alerts or as a point of care
decision aid, suggesting approaches for tailored risk reduction. Ultimately, it would improve monitoring of
population health and safety among Veterans and should facilitate precision medicine in diabetes care, with
the emergence of optimal, tailored, and patient centered approaches for managing diabetes.

Public health relevance
Fundamental to diabetes treatment is the control blood sugar to delay the onset of complications such as eye and kidney problems. Effective treatment may be limited by concern over hypoglycemia (low blood sugar), a common and potentially hazardous side effect. To monitor for this side effect and improve the safety of care for Veterans with diabetes, this study will identify patients with hypoglycemia using patient surveys and searches of text in medical records for notation by clinicians. Other information will be collected in surveys and from the electronic health record and used in predicting which patients will have hypoglycemia. The best set of predictors will be used in assigning risks to diabetes patients. The new methods for finding hypoglycemia and identifying those diabetes patients at high risk will be applied in a national automated system for use in monitoring patient safety and improving care to reduce risks.